Precision Prophylaxis of Surgical Site Infection Utilizing Pharmacomorphomics

Surgical site infection (SSI) is the most common healthcare-associated infection in the United States, impacting
160,000-300,000 patients each year. The incidence and morbidity of SSI are particularly great in colorectal surgical
procedures, especially among patients with comorbid obesity. SSI has been demonstrated to more than double the mean
cost of colorectal surgery ($31,933 vs $14,608) and increase the probability of readmission from 6.8% to 27.8%. A 2011
analysis of 89,148 patients by the American College of Surgeons found that obesity and morbid obesity increased the odds
of SSI in abdominal procedures by 1.8- and 2.5-fold, respectively, independent of diabetes and procedure type.
The mechanisms by which obesity drives SSI risk remains unclear. These may include comorbid conditions,
operative complications, and reduced tissue penetration of antimicrobial prophylaxis. Despite the profound increase in
the prevalence of obesity among surgical patients in the US, current antibiotic prophylaxis guidelines for colorectal surgery
do not include tailored dosing recommendations for body size or composition, with the exception of increasing the dosing
of cefazolin from 2g to 3g for patients over 120 kg. Multiple recent studies clearly show that obese patients fail to achieve
and maintain therapeutic tissue concentrations at operative sites during surgery. Utilizing analytic morphomics based on
high-throughput analysis of medical imaging scans (CTs) to precisely quantify body dimensions and composition, we have
identified multiple measures that predict SSI risk. We have also identified morphomic measures that are prime
determinants of antibiotic pharmacokinetics in patients.
We hypothesize that morphomic measures of body dimension and composition, derived from medical imaging,
can most accurately predict plasma and tissue drug concentrations of perioperative prophylactic antibiotics, and thus
inform personalized dosing recommendations for obese patients. Our specific aims are therefore to: 1) Compare
morphomic metrics to standard body-size measures as predictors of plasma and surgical site tissue concentrations of
preoperative prophylactic, 2) Develop a pragmatic dosing algorithm based on morphomics and other identified patient
variables to achieve and maintain therapeutic antibiotic levels at surgical sites, and 3) Pilot and evaluate the effectiveness
of this morphomic-based precision antibiotic prophylaxis regimen for colorectal resections in preparation for large-scale
dissemination by surgical quality collaboratives.

Public health relevance
Surgical site infection (SSI) is the most common healthcare-associated infection in the US, impacting 160,000-300,000 patients each year, and the incidence and morbidity of SSI are particularly great in colorectal surgical procedures, especially among patients with comorbid obesity. Despite the profound increase in the prevalence of obesity in the US, current antibiotic prophylaxis guidelines for colorectal surgery do not include tailored dosing recommendations for body size or composition, with the exception of increasing the dosing of cefazolin from 2g to 3g for patients over 120 kg. This study will leverage analytic morphomic measures of body dimension and composition, derived from medical imaging, to accurately predict plasma and tissue drug concentrations of perioperative prophylactic antibiotics, and thus inform personalized dosing recommendations for obese patients.